Contribution of Sleep Disruption to Memory Impairment and Emotion Dysregulation in Fetal Alcohol Spectrum Disorders

ABSTRACT
Prenatal alcohol exposure (PAE) is associated with a broad range of adverse and enduring consequences,
including impaired learning and memory and altered responses to emotion-laden events (i.e., emotion
dysregulation). Although sleep problems are often noted in epidemiological studies and clinical case
reports relating to fetal alcohol spectrum disorders (FASD), they have not been well characterized using
objective methodologies, such as polysomnography (PSG). Moreover, no studies have explored possible
associations between sleep problems and memory and emotional regulation impairments in FASD.
Investigation of these associations is warranted because healthy sleep is known to play a critical role in the
consolidation of newly-acquired declarative memories and to attenuate emotional reactivity to affectively-
valenced stimuli. The proposed study will be the first to investigate sleep architecture and its relation to
memory consolidation and emotional regulation in FASD. 90 young adults (18-21 yr of age; 30 fetal alcohol
syndrome (FAS) or partial FAS (PFAS), 30 non-syndromal heavily-exposed, and 30 non-exposed controls)
will be recruited from PI Sandra Jacobson’s and Co-I Joseph Jacobson’s well-characterized Cape Town,
South Africa, FASD cohort, which has been followed longitudinally since infancy. The data will be collected
in PI Thomas’s Sleep Sciences Laboratory at the University of Cape Town. Cape Town is an excellent
venue for this study given the unusually large number of individuals with heavy PAE and FAS available at a
single site and the availability of a state-of-the-art PSG-equipped laboratory. Sleep data will be obtained
over three consecutive nights. The 1st (adaptation) night will allow participants to acclimate to the sleep
laboratory’s environment and to sleeping with monitoring equipment attached. Sleep on the 2nd night will be
preceded by learning trials of standard declarative memory tests, which have been found to be affected by
PAE, and will be followed in the morning by delayed recall trials. This procedure will allow us to examine
associations between sleep disruption and memory consolidation. Sleep on the 3rd night will be preceded
by initial viewing of valenced pictures and will be followed in the morning by viewing of the same stimuli.
Psychophysiological measurement during both pre- and post-sleep viewing will allow us to examine
associations between sleep disruption and affective arousal/emotion regulation. The aims are (1) to
characterize sleep architecture of young adults with FASD; (2) to test the hypothesis that reductions in
slow-wave sleep (SWS) percentage will mediate PAE-related disruptions in memory consolidation; and (3)
to test the hypothesis that reductions in rapid eye movement (REM) sleep percentage will mediate PAE-
related alterations in emotional reactivity to previously-viewed emotionally-valenced pictures. If the
predicted associations are observed, sleep-based interventions may offer important and novel pathways for
addressing deficits in declarative memory and emotion regulation in FASD.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Epidemiological studies and clinical case reports often note the presence of sleep problems in individuals affected by prenatal alcohol exposure (PAE). Although an independent literature documents the importance of healthy sleep for the consolidation of newly-acquired declarative memories and the attenuation of emotional reactivity to affectively-valenced stimuli, no previous study has explored possible associations between disrupted sleep and the memory and emotion regulation difficulties that characterize the neurocognitive profile of fetal alcohol spectrum disorders (FASD). The proposed study will provide new information about the specific aspects of sleep architecture, that is, slow-wave sleep (SWS) and rapid eye movement sleep (REM), affected in FASD and the consequent effects on memory consolidation and emotion regulation, and thus has considerable potential to lead to the development of innovative and effective FASD intervention strategies related to sleep disruption.